EXERCISE AND GLUCOSE REGULATION IN AGING

Older age is associated with a decline in glucose tolerance which itself is an important precursor to the development of non-insulin-dependent mellitus (NIDDM) and subsequent cardiovascular disease (CVD). We propose that the decline in glucose tolerance with aging can be accounted for, to a significant extent, by the concomitant decline in physical activity. Thus, the overall purpose of the proposed study is to determine the impact of aerobic exercise on improvements in glucose regulation in older people.